Does Epstein-Barr Virus(EBV)Cause Systemic Lupus Erythematosus SLE)?

A complete understanding of disease is not possible without being conceptually grounded by etiology. Many
findings are consistent with the possibility that Epstein-Barr virus (EBV) is an etiology for Systemic Lupus
Erythematosus (SLE), but none that establish EBV as an original cause of SLE. We propose to extend our
continuing work using sera collected over time from active duty military, available through the Department of
Defense Serum Repository (DoDSR), and apply a Matched Etiologic Exposure Window (MEEW) strategy to
test whether EBV is, indeed, an etiology of SLE. The exposure window is defined from the moment that the first
serum is collected to the time that the serum is collected containing the earliest SLE-specific evidence of an SLE
pathologic process. During the exposure window, under the expectation that pre-disease cases and matched
controls are indistinguishable, variables that do not affect SLE etiology will follow the null expectation of
equivalence in the Cases and Matched-Controls. We will test whether EBV infection and anti-EBNA1 antibodies
deviate from the expected null distribution. If the associations are obtained and cannot be alternatively explained,
by error, reverse causation, confounding, or pleiotropy, then we conclude that the exposure showing association
is probably a causal etiology. This approach has been recently used to establish that EBV is a cause of Multiple
Sclerosis (MS) with Hazard Ratio (HR)=32, p<0.0001, in the absence of any evident alternative explanation.
We have had much experience working with sera and data from the DoDSR, publishing 11 DoDSR papers
describing the sequence of events that occur before the SLE is apparent. This experience allows us to make
reliable estimates of the needed sample size and establishes technical competence with the needed assays and
analyses. To obtain an adequate sample size we will include Veterans seeking healthcare in the US Department
of Veterans Affairs (VA) who had their first diagnosis of SLE in the VA soon after DoD service separation.
We will test the hypothesis that EBV causes SLE using the MEEW approach. We will ascertain alleged SLE
cases, identify those satisfying SLE classification criteria, and test their first DoDSR serum samples for the EBV
infection and anti-EBNA1 antibodies. Our published data are consistent with anti-EBNA1 antibodies being the
primordial precursor from which SLE-specific autoantibodies develop via molecular mimicry mechanisms.
Experiment 1 will test whether EBV-infected and anti-EBNA1 negative (EBV+/aEBNA1−) Cases develop anti-
EBNA1 more frequently in the exposure window than do Matched-Controls who are also EBV+/aEBNA1− and
matched on age, ancestry, sex, time of service, serum samples available, and, for VA-ascertained SLE cases,
time of first seeking VA care. The relationship of the appearance of anti-EBNA1 in relation to the appearance of
SLE-specific antibodies will define the exposure using conditional logistic regression for matched cases and
controls. Experiment 2 will then perform a MEEW analysis on Cases and Matched-Controls who have not been
infected by EBV using serology (EBV−) in their first, earliest DoDSR serum sample to determine whether EBV
infection (EBV+) occurs more frequently in Cases than in Matched-Controls during the exposure window.
Experiments 3 will test pleiotropy. Expt. 3.A. will test the cytomegalovirus (CMV) antibody serology transition
from the absence of anti-CMV (CMV−) to its presence (CMV+) using MEEW. Expt. 3.B. will compare cases to
controls at the point that SLE-specific autoantibodies first appear using a phage display library to evaluate the
relative antibody responses >400 viruses. If our ideas are correct, then the results will provide strong inference
that EBV and anti-EBNA1 are etiologic causes of SLE without evidence supporting an alternate explanation. The
mechanisms causing SLE via EBV would then become the focus of future academic and commercial research,
resulting in better diagnostics, therapeutics and management, and, even, preventive measures, eliminating risk
of SLE (e.g., a successful anti-EBV vaccine) or that abort the disease process in its nascent form, all of which
would benefit the next 30,000 active-duty military and Veterans who otherwise will be on a path to develop SLE.

Public health relevance
The origins or causes of diseases are the foundations upon which the pathological process proceeds from step to step, culminating in clinical morbidity and mortality. For systemic lupus erythematosus (SLE), extensive evidence establishes a strong relationship with Epstein-Barr virus (EBV) of uncertain relevance. We will use advanced scientific strategies to test the specific idea that SLE is caused by not only EBV, but also by the antibody generating immune response against EBV in the SLE patient. These studies, if successfully implicating EBV as a cause of SLE, would then lead the research community to re-emphasize the importance of discovering mechanisms leading from EBV to SLE. SLE has affected nearly 30,000 US Veterans with a predilection for affecting Veteran women (14 to 1 over men) and Veteran African-Americans (6.2 to 1 over European- Americans). This project, with its improved understanding of SLE origins, will ultimately bring better care and management for Veterans with this potentially deadly disease and strategies for preventing SLE all together.